Role of NLRs in Melanoma

Background and Innovation: Inflammation is one of the hallmarks of cancer, whose dysregulation is
associated with unfavorable clinical prognosis in cancer patients. We have reported the activation of the
“inflammasome,” a multi-protein complex responsible for caspase-1 activation and subsequent IL-1β
secretion, as a mechanism of tumor progression, drug resistance, and immune suppression in human
melanoma. The pro-tumorigenic role of inflammasomes has also been reported in other cancers. However,
few studies have investigated the molecular mechanisms of inflammasome activation in cancer cells.
Using The Cancer Genome Atlas (TCGA) data, we found that the inflammasome sensor NLRPs are highly
mutated in melanoma, with 65.5% of melanoma (284 of 440 tumors) harboring somatic missense mutations.
In contrast, mutation rates are low in other inflammasome genes, such as PYCARD (ASC gene), CASP1, or
CASP5. Although the consequences of NLRP mutations in tumor cells are unknown, melanoma mutations in
NLRP3 overlap with gain-of-function mutations in cryopyrin-associated periodic syndromes (CAPS), and
preliminary data support our hypothesis that the somatic missense mutations in NLRP3 alter the structure of
NLRP3 and activate NLRP3 inflammasome, leading to tumor progression in human melanoma. This is the
first report of molecular mechanisms connecting somatic missense mutations in NLRP3 to inflammasome
activation and tumor promotion. In addition to the conceptual innovation, our proposal uses a novel assay to
model cancer-related somatic missense mutations in NLRP3 in silico and assess the effects of NLRP3
inhibitors on ATP binding affinity in the presence of mutations.
Significance and Impact to Veterans Healthcare: Melanoma represents 4% of skin cancers but is
responsible for 64% of skin cancer-related deaths. Sun exposure is part of daily life for US troops, especially
during summer, and is linked to a higher incidence of melanoma. The risk of developing melanoma is
increased in individuals who experience sunburn at an early age, including young women who play an
increasingly important role in the VA population. Additionally, skin conditions such as skin cancers are a
significant reason for the medical evacuation of soldiers during US military service. As a result, the economic
burden of this malignancy is substantial, driven by both the rising direct costs of melanoma treatment and the
indirect costs associated with productivity losses. We will investigate the molecular mechanisms of
inflammasome activation and tumor progression by studying somatic missense mutations in NLRP3 in human
melanoma cells and treating these cells using various inflammasome inhibitors.
Path to translation/implementation: In this proposal, we will define the structural changes (Aim 1),
biochemical and biological effects of somatic NLRP3 mutations (Aim 2), and their impacts on the therapeutic
effects of inflammasome inhibitors in melanoma (Aim 3). Recent reports of the inflammasome structure and
inhibitor binding of NLRP3 provided new insights into its mode of action and inhibitor-NLRP3 interaction at
molecular levels, creating a framework for developing more effective and specific NLRP3 inhibitors against
chronic diseases with major health concerns. Since inflammasome mutations can change their protein
structures and compromise the interactions with their protein partners or inhibitors, elucidating the structure
and its binding with protein partners and inhibitors at molecular levels in tumor cells is critical for clinical
success in melanoma and potentially other cancers that carry mutations in NLRPs. Given the safety profile
and clinical availability of many inflammasome inhibitors, promising findings in the current proposal could be
easily translated into patient care. Furthermore, our study will allow us to modify the existing inhibitors using
the structure-based drug design to develop novel inflammasome inhibitors with improved efficacy and
specificity against melanoma cells carrying inflammasome mutations in the future.

Public health relevance
Melanoma has a high propensity for metastasis and accounts for most skin cancer-related deaths. The risk of developing melanoma doubles if an individual is exposed to >5 sunburns at any age. Sun exposure is part of the daily life of U.S. troops, and exposure during U.S. military service is linked to increased melanoma incidence. Furthermore, melanoma is more common than other cancers in young women, an increasingly significant V.A. and active-duty military population. Despite the remarkable progress in melanoma therapeutics, melanoma remains a challenge in clinical oncology. Inflammation is associated with unfavorable clinical prognosis in many cancer patients. This new project aims to study how DNA changes in inflammasome sensors (controlling cytokine secretion) affect melanoma progression. Understanding the mechanisms of tumor-induced inflammation is vital for clinical success in melanoma and other cancers for V.A. patients.